Development of a novel syphilis molecular diagnostic assay for a point-of-care multiplexed genital ulcer panel test on giant magnetoresistive biosensors

PROJECT SUMMARY
There is a large unmet need for fast and effective point-of-care (POC) molecular diagnostic (MDx) testing for
congenital and adult acquired syphilis. Current syphilis detection methods utilize dark-field microscopy and/or
serum antibody tests that are performed in a centralized lab, require a trained operator, have inadequate
sensitivity and specificity without confirmatory reflex testing, or have long turnaround times on the order of
days. These challenges prevent clinicians from obtaining immediate and definitive test results to provide
patients with the correct treatment before patients leave the clinic.
The goal of our proposal is to develop a POC PCR-based syphilis assay as part of a multiplexed genital ulcer
disease (GUD) assay panel on GMR biosensors and to determine the best sample type or pooling of sample
types, for molecular detection of congenital, secondary, and latent syphilis. GMR biosensors are
magnetic-based field sensors that provide several advantages over conventional fluorescent and optical-based
detection methods. They offer lower background noise and a higher signal-to-noise ratio due to sample matrix
insensitivity. Additionally, GMR biosensors do not need complex and expensive components for signal readout
and processing or light compensation that are required for more traditional methods. Therefore, our
MagChipRTM platform can be made truly point-of-care, portable, affordable, and accessible by reducing
footprint and cost while maintaining a simple user workflow for untrained operators. This platform has
previously demonstrated successful multiplexed detection of Chlamydia trachomatis (CT), Neisseria
gonorrhoeae (NG), Trichomonas vaginalis (TV), and Mycoplasma genitalium (MG) in a single test.
Given the advantages of our platform, and our knowledge and skill sets in developing GMR-based molecular
assays, we aim to achieve the goal of our proposal with the following Specific Aims: 1) Develop POC
multiplexed PCR/GMR-based molecular assay for Treponema pallidum and other pathogens causing genital
ulcer disease, and 2) Clinical validation of GUD assay in patients with primary syphilitic lesions and discovery
of novel biospecimens and/or pooled specimens for various syphilis disease stages. Ultimately, this assay
panel will be run on our fully automated, raw sample-to-result MagChipRTM platform to provide clinicians with
diagnostic tests results in 20 minutes and enable them to give patients immediate and definitive treatment
before their patients leave the clinic. This assay would be one of the first commercially available POC NAAT for
syphilis, and in combination with our other STI assay panels, we hope to offer clinicians and patients with a
solution for comprehensive STI testing.

Public health relevance
PROJECT NARRATIVE Current syphilis detection methods, especially serological ones, are typically laboratory-based, require a secondary confirmatory assay to reach adequate sensitivity and specificity, and are characterized by challenges that prevent clinicians from obtaining immediate and definitive test results for effective treatment decisions before the patient leaves the clinic. Our multiplexed MagChipTM genital ulcer disease assay and MagChipRTM analyzer will provide one of the first commercially available POC NAAT solutions that will enable untrained users in CLIA-waived settings to discriminate syphilitic ulcers from ulcers caused by other ulcerative diseases. In addition, NAATs currently lack sensitivity outside of primary genital lesions – our robust MagChip chemistry is compatible with multiple sample types, which we will leverage in an innovative clinical study, pooling multiple sample types from the same patient to enhance the sensitivity of our MagChip T. pallidum assay for diagnosing secondary, latent, and congenital syphilis.